Obesity and diabetes genetics in Caenorhabditis elegans.

DESCRIPTION (provided by applicant): This proposal describes a five year plan for Alexander Soukas to transition to an independently-funded investigator with expertise in functional genomics of obesity and diabetes. Dr. Soukas, an instructor in medicine and assistant in molecular biology at Massachusetts General Hospital, will be mentored by Gary Ruvkun, Ph.D., professor of genetics at Harvard Medical School. Dr. Ruvkun is a worldwide expert in C. elegans biology, metabolism, genetics, and genomics, a Lasker Award winner, and has a very strong record of mentorship, having supervised 38 trainees, 24 of which have academic, tenure-track faculty positions. An advisory committee of physician-scientists with expertise in human genetics, lipid metabolism, cell signaling, and mitochondrial biology made up of David Altshuler, M.D., Ph.D., Joseph Avruch, M.D., Mason Freeman, M.D., and Vamsi Mootha, M.D. will provide scientific direction, ground the investigator in medically-relevant lines of research, and provide career guidance during the transition to independent investigator. Dr. Soukas will carry out the planned career development activities in the research and training environment at the Massachusetts General Hospital and Harvard Medical School. The research program proposes use of the organism C. elegans to identify candidate genes involved in the pathogenesis of obesity and diabetes. Obesity and type 2 diabetes are extremely prevalent, highly associated diseases that cost the US more than $174 billion in 2007, and produce an even greater cost on society in terms of life-years lost. Given the tremendous conservation in ancient pathways regulating energy homeostasis, we hypothesize that identification of conserved genes regulating fat in C. elegans will illuminate human genetic pathways regulating energy homeostasis, and possibly even obesity and diabetes disease mechanisms. Preliminary studies on C. elegans have isolated more than 50 mutants with altered fat content. Those most notable identified to date are the conserved genes rictor, an essential component of target of rapamycin complex 2 (TORC2) protein kinase, and serum and glucocorticoid-induced kinase (sgk-1), an Akt-related kinase that acts downstream of TORC2. Completed studies of C. elegans rictor indicate that it is a central regulator of metabolism, controlling fat mass, growth, reproduction, and lifespan through regulation of the kinases AKT and SGK4. The investigator will learn to apply genomics (RNA interference, whole-genome sequencing, high-throughput technology), forward genetics, and biochemistry 1) to identify new mutations in genes that alter C. elegans fat content, 2) to determine the cellular and molecular mechanism by which altered fat mass is generated in rictor/TORC2 and other mutants, and 3) build a network of genetic interactions regulating body fat. The ultimate goals of this work are to identify and characterize genes that play a conserved role in energy homeostasis in C. elegans and humans, to inform human genetic and mouse model studies of obesity and diabetes, and to transition to independent investigator status.

Public health relevance
PUBLIC HEALTH RELEVANCE: Obesity and type 2 diabetes are associated diseases well recognized to be among the leading causes of premature illness and death. This career development award proposes training to establish the applicant as an independent investigator in the area of obesity and diabetes gene discovery, using new technology and a genetic system where the role of every gene can be examined systematically. Discovery of obesity and diabetes candidate genes will help both to inform future study of metabolic diseases and to design intelligent therapies to combat these devastating diseases. RELEVANCE: Obesity and type 2 diabetes are associated diseases well recognized to be among the leading causes of premature illness and death. This career development award proposes training to establish the applicant as an independent investigator in the area of obesity and diabetes gene discovery, using new technology and a genetic system where the role of every gene can be examined systematically. Discovery of obesity and diabetes candidate genes will help both to inform future study of metabolic diseases and to design intelligent therapies to combat these devastating diseases. __SpecificAimsTextDelimiter__ RESEARCH PLAN: Specific Aims: A better understanding of the molecular mechanisms underpinning the development of obesity and diabetes is crucial for design of the next generation of therapies. C. elegans, through its facile genetics, genomics and genetic conservation provides a platform in which genetic pathways regulating metabolism at a level of the whole organism can be elucidated at a pace not possible in mammalian systems. This career development award proposes two specific aims. The first involves the applicant learning to use and apply genomics to existing efforts on classical genetics of fat metabolism to build a network of metabolic regulators. The second details more in-depth investigation of fat and growth regulation by target of rapamycin complex 2 (TORC2) signaling using newly acquired genomic expertise and biochemical approaches. This work is thematically related to the mentor's use of genomic techniques to study various biological phenomena in C. elegans, but is differentiated from the mentor's research program in its use of genomics to conduct in-depth exploration of specific pathways regulating energy homeostasis. 1) Identify key fat regulatory genes using high throughput genetics, genomics, and a validated method for assessing fat mass newly applied to C. elegans. 57 genetic mutants with altered lipid homoeostasis have been isolated. While the causative mutation for several of these have been identified, other candidates await identification. A new method for assessment of neutral lipid stores using the histochemical dye oil-red-O was developed that accurately depicts C. elegans lipid stores, when compared to biochemical quantitation of triglycerides with gas-chromatography/ mass spectrometry, the gold standard. We demonstrated that previous methods used in C. elegans, including labeling with the vital dye Nile red and BODIPY-labeled fatty acids, stain lysosomes, or acidified cellular compartments, not lipid droplets (preliminary studies). Thus, these reagents are unsuitable for comprehensively studying fat metabolism by whole-genome RNAi. I propose using our validated method of oil- red-O to comprehensively study the C. elegans genome for fat regulatory genes. A) Whole-genome sequencing will be used to identify mutations causing altered body fat mass. The technology permits several different mutations to be identified in parallel in weeks. B) Apply quantitative microscopy to analyze oil-red-O staining of animals treated with RNAi to 1000 metabolic genes. This sub aim will establish the first "core metabolism sublibrary", genes that affect fat mass in wild- type worms. In later years of this proposal, when the efficiency of automated quantitative microscopy and image analysis improves, this will be done on whole-genome scale, in many genetic mutants. C) Conduct RNAi to the core metabolism sublibrary genes in mutants identified in aim 1A to determine the dependence of the high fat phenotype on each key metabolic gene. Oil-red-O staining and quantitative microscopy will be used to quantitate effects of each RNAi inactivation on fat mass. D) Generate quantitative, real-time RT-PCR assays for each gene in the core metabolism sublibrary to determine if they are differentially regulated at the mRNA level in fat mutants identified. E) Assess whether RNAi of the core metabolism sublibrary genes leads to alterations in insulin-like signaling and mitochondrial function by examining the effect of RNAi on nuclear localization of a FOXO::GFP translational fusion protein, expression of insulin promoter::GFP fusion transgenes, or a mito::GFP reporter. F) Examine tissue of action for fat genes from aim 1A by use of GFP reporter constructs to illuminate tissues of expression, tissue-specific RNAi (developed by the Ruvkun laboratory) and tissue-specific rescue. G) Explore fat storage by conducting RNAi to 2700 essential genes post-developmentally. These genes cause lethality during development and have not been studied for a role in fat storage thus far. H) Learn to use a wormsorter to isolate and clone mutants with altered fat levels generated by transposon- mediated mutagenesis. Transposons allow rapid identification of mutated genes from a single worm. 2) Identify the molecular mechanisms by which target of rapamycin complex 2 (TORC2) mutants produce metabolic defects. Mutations in essential components of the evolutionarily conserved protein kinase complex TORC2 were identified to have elevated lipid stores at the expense of slow growth, small body size, short lifespan, and decreased reproductive potential4. Our previous work identified that TORC2 acts in the main fat storage organ of C. elegans to produce these effects, and acts through the downstream effector kinases AKT and SGK. Preliminary genomic, genetic, and biochemical approaches have identified 22 new potential candidate genes involved in the TORC2 signaling, 150 uncloned genetic mutants which suppress phenotypes of TORC2 mutants, and a number of candidate proteins. The goal of these studies is to elucidate the transcellular and intracellular signal transduction cascade upstream and downstream of TORC2 using genetic, genomic, and biochemical approaches. A) Establish whether 22 genes that phenocopy rictor by RNAi operate in the TORC2 pathway. Assess fat mass, body size, growth, lifespan, and reproduction in double mutants. B) For candidate protein kinases thought to be in a pathway with TORC2, generate high copy overexpression transgenics and/or single copy gain of function transgenics in rict-1 mutants to determine if mutant phenotypes are suppressed. C) Use whole genome sequencing to identify the most promising of the 150 suppressors of TORC2 mutant phenotypes isolated from a genetic screen. D) Identify protein-protein interactors of AKT and SGK in TORC2 mutants using immunoprecipitation of tagged AKT and SGK, silver staining, and protein mass spectrometry. E) Western blotting revealed proteins containing the AKT/SGK kinase target motif (RXRXXS/T-phosphate) that are no longer phosphorylated in TORC2 mutants. Immunoprecipitation, high-resolution electrophoresis and mass spectrometry will be used to identify these RXRXXS/T proteins. F) A phosphopeptide map of the C. elegans genome has been established11. We will use this database to establish all possible AKT/SGK phosphorylated targets. Using genomic strategies from aim 1B, RNAi, high- throughput microscopy, and oil-red-O analysis will be conducted to determine if these targets are operative in the TORC2 pathway. G) Using high-throughput quantitative microscopy on TORC2 mutants, conduct RNAi to the core metabolism sublibrary identified in aim 1B to identify the mechanism of altered fat levels. Conduct quantitative PCR on each of these genes using the assays developed in aim 1D.